Research Training in Complementary and Integrative Medicine

Project Summary/Abstract
This proposal is for a five-year continuation of the Harvard Medical School Research Fellowship
Program in Integrative Medicine (IM). This three-year program prepares both clinician and non-
clinician post-doctoral fellows for successful careers as academic research faculty and
educators. The Harvard-wide program is based within the Division of General Medicine and
Primary Care at Beth Israel Deaconess Medical Center with continued close collaboration with
the Harvard Medical School (HMS) Osher Center for Integrative Medicine, an inter-institutional
program that facilitates the development of research and education across Harvard in this
emerging field. The training program focuses broadly on mind-body therapies (including yoga,
tai chi, meditation, and the placebo phenomenon), that are areas of faculty expertise. Faculty
mentors have funded research programs in IM research and track records of successful
mentoring. Most trainees earn an MPH degree during the first two years of fellowship at the
Harvard T.H. Chan School of Public Health (HSPH). The master's program includes the
Program in Clinical Effectiveness, an intensive summer curriculum in epidemiology, biostatistics,
and health services research. Throughout the fellowship, weekly programs including seminars in
research methodology/skills (e.g. study design, grant writing, publications) and a core program
in evidence-based IM, provide specialized clinical, research and scholarly skills in IM. Fellows
can also take in-depth courses in IM in order to acquire practitioner skills/certification to inform
their research. Most of the trainees' time is devoted to mentored research. Each uses skills
learned in the classroom to develop, conduct and analyze at least two original investigations in
IM under the direction of experienced faculty mentors. Research may span clinical trials,
epidemiology, health services research, basic science and translational methodologies from
bench to bedside. Fellows also participate in experiential retreats in IM and have opportunities
to teach IM at HMS. Fellows may develop clinical skills in IM at one of several available
integrative practice sites. A principal research mentor, clinical preceptors, and an advisor at
HSPH supervise each fellow's development. Over the first 18 years of the fellowship, 28 fellows
have completed the program and most have earned an MPH. Most graduates have continued in
academic medicine; twelve have been awarded K series career development awards. All
graduated fellows have published peer-reviewed research manuscripts, with over 175
manuscripts published from fellows' work over the years.

Public health relevance
Project Narrative This training program is relevant to public health because it trains individuals to perform scientifically-based research in the developing field of integrative medicine. This is an important area of clinical care that is used widely by the public but requires further research to understand mechanism, efficacy, cost effectiveness, and translation to modern healthcare.